Administration

The Administrative Core will provide administrative support and services to the Program Director and each investigator In the Program. The Program Director is responsible for supervising the Program and coordinating interactions between the Investigators and Core B, and will need the assistance of this core to carry out that function. The Core will also arrange travel, arrange outside and inside seminars and meetings, prepare Progress reports and slides for presentations among the investigators and in outside forums. The Core will coordinate the International Workshop on "Immunity at the Mucosa" proposed for 2009 at the Trudeau Institute. RELEVANCE (See instructions): The function of coordinating meetings and data exchange is particularly crucial to achieving the goals of the program to develop a comprehensive understanding of the impact of aging on immune response to infectious disease and our ultimate attempts to find strategies to overcome those defects.